EDAC: ENCODE Data Analysis Center

PROJECT SUMMARY
The goal of the Encyclopedia of DNA Elements (ENCODE) project is to catalog all functional elements in the
human genome through the integration and analysis of high-throughput data. We propose to continue the
ENCODE Data Analysis Center (EDAC, DAC) which will provide support and leadership in analyzing and
integrating data from the ENCODE project as well as work closely with other ENCODE groups including the
Data Coordination Center. Our proposed DAC team has expertise across a wide range of fields including
transcriptional regulation, epigenetics, evolution, genomics and proteomics, regulatory RNA, biophysics, and
computational biology, where they are the leaders in machine learning, statistical genetics, networks, and gene
annotation. These investigators also have a history of successfully working collaboratively in large consortia,
particularly with other ENCODE groups. Their publication records demonstrate their synergistic approach to
producing high-impact science and useful resources that benefit the broader biomedical communities.
The proposed DAC will pursue the following four aims: Aim 1. Analyze and integrate data and metadata from a
broad range of functional genomics projects; Aim 2. Serve as an informatics resource by supporting the
activities of the ENCODE Analysis Working Group; Aim 3. Create high-quality Encyclopedias of DNA elements
in the human and mouse genomes; Aim 4. Assess the quality and utility of the ENCODE data and provide
feedback to NHGRI and the Consortium.

Public health relevance
RELEVANCE The goal of the Encyclopedia of DNA Elements (ENCODE) project is a highly collaborative effort aiming to develop a comprehensive list of functional elements in the human genome. This proposal creates a data analysis center to provide support and computational prowess for this effort in collaboration with other ENCODE groups. This comprehensive list will be of use to the wider research community and will aid in understanding human biology particularly in the context of disease, ultimately leading to improvements in human health.